Establishment of a Cell-Based Screening Platform for DNA Encoded Libraries

Project Summary
DNA-encoded library (DEL) technology has revolutionized the discovery of protein-
binding small molecules. However, traditional DELs, where every molecule is connected
to an encoding DNA and the library is produced as an intractable mixture, have not been
useful for functional and phenotypic screening. We have been involved in the
development of one bead one compound (OBOC) DELs, which can be used for functional
and cell-based screens since beads are separable and only a small percentage of the
molecules on the beads are linked directly to a DNA encoding tag. To date, the very small
number of papers that have described activity-based screens of OBOC DELs have
required the use of highly sophisticated microfluidics technology. This project will
develop a cell-based screening platform for OBOC DELs that will not require any
specialized equipment. If successful, this will make this powerful approach to the
discovery of bioactive molecules far more accessible to the chemical biology community.

Public health relevance
Project Narrative This project will attempt to establish a platform in which one bead one compound (OBOC) DNA-encoded libraries (DELs) can be screened cheaply and efficiently for compounds that affect a biological process of interest in a living eukaryotic cell. If successful, this project will make functional screening of DELs far more accessible to the chemical biology community since it will require no specialized equipment. This should spur the discover of a host of new, bioactive molecules.